Unraveling Epigenetic Mechanisms Of Opioid Addiction Susceptibility Using Multigenerational Animal Models

PROJECT SUMMARY Drug addiction is a massive public health concern that inflicts extensive burdens on our economy and society. The harmful consequences of drug abuse extend far beyond the addicts and gravely impact their families. A growing body of evidence suggests that the children of fathers who consumed drugs around the time of conception show altered brain function and behavioral abnormalities. We have established a highly translational paradigm of paternal opioid drug taking, using morphine self-administration in rats to study this phenomenon. Our results demonstrate that the male progeny of fathers (sires) that took morphine chronically are more susceptible to develop addiction-like traits and self-administer morphine. This multigenerational animal model offers a rare window into a pool of subjects that are more vulnerable to develop addiction, a population that has been historically difficult to identify. Here, we can reliably and systematically produce animals that show increased drug taking behavior, which offers a unique opportunity to delve into the mechanisms underlying addiction susceptibility. This multifaceted project will combine behavioral and molecular biological approaches to identify functionally relevant mechanisms that confer a higher propensity to develop addiction. The parent award and related studies address two major questions: (1) which germline epigenetic reprogramming events are critical for shaping development toward addiction vulnerability into adulthood? (2) what are the functionally relevant neuro-epigenetic processes that increase addiction-like behavior in our multigenerational model of drug taking? This supplement will support a NIDA summer intern who will be trained to develop research skills including data collection, data management, statistical analysis and dissemination (written and oral) or results.

Public health relevance
PROJECT NARRATIVE: Mounting evidence suggests that environmental factors in adults can have a substantial impact on the behavior and neurobiology of their offspring. We will use a multigenerational animal model of opioid addiction to examine the molecular mechanisms underlying addiction susceptibility. The signaling pathways identified under this proposal are potential targets for therapeutic development to treat substance use disorder.